Optimizing Therapeutic Revascularization by Endothelial Cell Transplantation

7. PROJECT SUMMARY/ABSTRACT
Tissue engineering through 3D printing is a promising approach to address the donor organ shortage that
severely limits the impact of transplantation therapy. Two current challenges in tissue engineering are how to
create a complex microvascular system with vessel segments of different caliber to provide effective graft
perfusion and how to prevent tissue engineered grafts made from allogeneic cell sources from triggering
immune-mediated rejection by the graft recipient. These problems are linked in that human endothelial cells
(ECs), required for perfusion, are immunogenic and can trigger rejection. We propose to address these
problems using synthetic skin as a model system. We have successfully developed bioinks containing human
fibroblasts (FBs), endothelial cells (ECs) and pericytes (PCs) from a single donor source and all cultured under
xeno-free conditions, within a matrix formed from human matrix proteins to create a papillary dermis with an
epidermis formed from keratinocytes (KCs), also from the same donor source and also cultured under xeno-
free conditions. In aim 1 we will optimize an additional bioink to create a collagen-dense reticular dermis as a
deep layer, adding vascular smooth muscle cells to drive formation of larger caliber vessels, thereby forming a
trilayered skin substitute. We will explore the use of delivering extracellular growth factors or intracellular gene
modifiers to enhance microvessel formation after engraftment on immunodeficient mouse hosts and we will
challenge engraftment by pharmacologically impairing wound healing. In aim 2, we will evaluate the
immunogenicity of these bioengineered skin constructs by engraftment on to human immune system mice,
using an established model as well as a new model with a more replete human immune system that has
myeloid and natural killer cells in addition to alloreactive human effector memory T cells. Finally, we will apply
state-of-the art genetic engineering or drug delivery approaches to reduce the immunogenicity of the
constituent graft cells, e.g., by ablation of HLA antigen expression, assessing whether this needs to be
performed on multiple cell populations. Our focus on skin as a target for generating a well perfused but non-
immunogenic engineered tissue also addresses an unmet clinical need and our use of wholly human
constituents to do so brings this closer to clinical translation. This project takes advantage of the synergistic
expertise of the two multiple principal investigators who have worked together for over a decade. Successful
completion of our aims will establish a prototype for developing a clinical therapeutic and will establish
principles with broad implications for tissue engineering and regenerative medicine.

Public health relevance
PROJECT NARRATIVE We propose to fabricate a human skin substitute that can be used to treat patients, and will use this project to address two problems that are common to tissue engineering of all vascularized replacement organs, namely how to incorporate a functional microvascular system for organ perfusion and how to avoid immune-mediated rejection by the graft recipient. We will introduce four innovations: (1) we will use the power of 3D printing to replicate the different layers of natural human skin; (2) we will use only human materials to avoid allergic responses; (3) we will create a well differentiated blood vessel system by combining different vessel wall cell types and novel approaches of drug delivery to promote robust and stable engraftment; and (4) we will use tools of genetic engineering (CRISPR/Cas9) and drug delivery to minimize immune-mediated rejection of the graft by human immune system mouse hosts. These advances will both improve upon current skin substitutes and will generate paradigms with broad applications to tissue engineering.